DEVELOPMENT OF APTAMERS TO RECOGNIZE NOD-LIKE RECEPTORS IN ZEBRAFISH

The goal of this project is to develop aptameric detection reagents for six zebrafish NOD-like receptors (NLRs) that recognize PAMPs & DAMPs in innate immune cells. Aptamers are an attractive alternative to antibodies as a high affinity reagent for specific binding and detection of proteins due to their structural diversity and ease of synthesis. The success of this project will yield aptamers for detecting important NLR targets to examine immune responses in the zebrafish model for immunology and infectious disease studies.